Mechanosensitive Ion Channels Modulation by Membrane Composition

Project Summary
Our current research focuses on investigating the mechanisms by which fatty acids (the building blocks of the
plasma membrane) modulate the function of mechanosensitive ion channels. These ion channels transduce
mechanical stimuli into electrochemical signals in all kingdoms of life. Members of the mechanosensitive ion
channel family (including the PIEZO channels) are involved in various physiological processes, including gentle
touch sensation, proprioception, musculoskeletal development, neuronal differentiation, cell volume, wound
healing, and food sensation. PIEZO channel dysfunction has a detrimental effect on human balance,
proprioception, skeletal development, mechanical allodynia, and erythrocyte volume. Since PIEZO channels play
critical roles in health and disease, it has become clear that modulating their function could have therapeutic
effects for a wide range of pathologies. Unfortunately, the pharmacology of PIEZO channels is in its infancy.
Hence, we envision that strategies fine-tuning PIEZO channel function will lay the groundwork for novel
pharmacological tools. In the past five years, we have identified dietary fatty acids that, when enriched in the
plasma membrane, fine-tune PIEZO channel mechanical responses in vitro, ex vivo, and in vivo. Noteworthy,
we have utilized fatty acid-enriched diets to ameliorate the deficits associated with increased or reduced PIEZO2
function in mouse models of neurological disorders. Our goals for the next five years are to depict the molecular
mechanisms by which saturated and polyunsaturated fatty acids modulate the function of bacterial and
mammalian members of the mechanosensitive ion channel family and develop strategies to ameliorate channel-
associated disorders. Furthermore, we will uncover novel physiological roles of the PIEZO subfamily using the
animal model C. elegans. Our functional, behavioral, and genetic studies will uncover unifying themes underlying
the modulation of mechanosensitive ion channels by membrane composition and reveal novel physiological roles
of this family of ion channels.

Public health relevance
PROJECT NARRATIVE Members of the mechanosensitive ion channel family act as biological sensors by decoding mechanical stimuli to regulate physiological processes such as touch and food sensation, mechanical pain, and wound healing. The proposed study is relevant to NIH's mission because it will provide the molecular basis by which fatty acids modulate the response of mechanosensitive ion channels, including the PIEZO family. The proposed research is relevant to public health because combining dietary fatty acids might be a new strategy to ameliorate mechanical pain and accelerate wound healing.